CARDIOVASCULAR DISEASE IN THE PIMA INDIANS

The Strong Heart Study is a study of cardiovascular disease (CVD) among American Indians. The study involves 12 Indian communities in Arizona, Oklahoma and The Dakotas. Phase I, which initiated on October 1, 1988, included a medical record review to determine mortality rates for CVD in individuals ages 35 to 74 years between 1984 and 1988 and morbidity rates for individuals 45 to 74 years. In addition, a physical examination was performed on all individuals 45 to 74 years old to measure prevalence of cardiovascular and peripheral vascular disease and known and suspected risk factors. This application proposes an extension (Phase II) of the Strong Heart Study in which the mortality survey will be continued, and the cohort of men and women examined during Phase I will be followed and re-examined. The aims of Phase II are to determine CVD mortality and morbidity rates in an examined cohort by surveillance, to determine CVD risk factors, the change in risk factors over time, and the relationship between risk factors and CVD. Additional aims are to compare CVD risk factors at the three centers to relate them to differences in the rate of CVD, to assess risk factors for CVD among diabetics compared to non-diabetic individuals, to investigate structural and functional cardiac disease using echocardiography, and to study pulmonary function to identify risk factors for pulmonary diseases and their relationships to CVD. Additional laboratory measurements will be added to expand the number of possible correlates with CVD, i.e., Lp(a), plasminogen and plasminogen activator inhibitor, and to asses degree of genetic admixture. This application is for the Arizona Field Center and for the Core Laboratory of the Strong Heart Study Phase II.